Pathology and Molecular Imaging Core

Core B (Pathology and Molecular Imaging Core) has expertise and facility that meets the need of individual projects for cardiovascular pathological studies and image analysis. It will provide standard service in routine histology and tissue processing as well as advanced microscopic analysis of isolated cells and subcellular preparations. Interacting with all the projects, the Core will develop common protocols and procedures to cell labeling, tissue processing and sectioning, immunohistochemistry, electron microscopy and cytological imaging. Preliminary data obtained from pilot studies have provided evidence supporting the feasibility of working hypothesis, histopathological research design in histopathology, and experimental protocols.

Public health relevance
RELEVANCE (See instructions): The relevance of the Core B is that the core will provide detailed histopathological and cytopathological analyses with imaging data to characterize vascular lesions and characteristics of smooth muscle cells and contratile filaments from normals and mutants for correlation with the molecular studies being conducted in the four projects of the PPG. The information obtained will have direct relevance for understanding the pathogenesis of aortic aneurysms and the subsequent diagnosis and treatment of affected patients.